Protocol Review and Monitoring System

CCSG COMPONENT 004 – PROTOCOL REVIEW AND MONITORING SYSTEM
PROTOCOL SUMMARY/ABSTRACT
The Scientific Review Committee (SRC) ensures that all cancer-relevant interventional trials conducted under
the auspices of Vanderbilt-Ingram Cancer Center (VICC) are of the highest scientific quality, follow responsible
conduct of research principles, and have significant potential impact for patients. In addition, there is an
intentional focus to develop a portfolio of interventional trials that meet the needs of the catchment area and
assure diversity of participants, and inclusion across the lifespan. Protocols requiring full committee review are
evaluated for appropriate scientific rationale, clearly defined specific aims, achievable study endpoints, research
integrity, a plausible biostatistical plan, feasibility, and a well-justified ability to accrue eligible patients from the
VICC catchment area. These criteria exist to ensure that the study design supports the completion of its scientific
goals. This focus on the scientific integrity of the trial clearly sets the SRC's role apart from the Vanderbilt
Institutional Review Board (IRB), in that the SRC is focused on sound science with potential of translation to
cancer care, while the IRB is primarily concerned with patient safety. The SRC and IRB have two separate
functions and yet both complement each other by ensuring the integrity of the study through a sound scientific
approach while also considering the protection of all participants. The IRB does not play a role in determining
the extent of Cancer Center support that a protocol should receive. However, the SRC is responsible for
prioritizing each protocol and providing recommendations regarding Cancer Center support, which includes CTO
work queue management and financial support for institutional trials or those not fully funded by an extramural
sponsor.
In addition to ensuring a high level of scientific merit and appropriate prioritization of VICC interventional trials,
the SRC oversees the progress of all active interventional protocols by routinely monitoring the patient accrual
and closing studies that do not demonstrate scientific progress and adequate accrual. Low accruing studies
involving rare diseases and studies that advance key areas of focus and align with the Cancer Center's strategic
plans will be given special consideration. The SRC will also review any protocol changes that have a significant
impact on the design or scientific rationale for an ongoing interventional trial. The SRC also reviews trials to
ensure that they are consistent with VICC's commitment to addressing health disparities in clinical trial
participation. The SRC provides special attention to trials targeting cancers that disproportionately affect minority
populations.

Public health relevance
CCSG COMPONENT 004 – PROTOCOL REVIEW AND MONITORING SYSTEM PROJECT NARRATIVE Per the PAR-17-095 FOA, the project narrative is not applicable for the Protocol Review and Monitoring System Core.